Changing brachytherapy with MRI remnant-tumor segmentation and active-catheter placement

Cervical cancer is a worldwide public health problem and significant cause of mortality, with over
500,000 women diagnosed each year. Optimal curative treatment for women with locally advanced disease
calls for treatment with external beam radiation (EBRT) followed by brachytherapy. Brachytherapy allows
delivering larger dose into the tumor with interstitial catheters, which are placed into the residual tumors that
survive EBRT. The placement of these catheters, hollow plastic tubes with metal rods placed inside for
pushing through body tissue, is typically done without any guidance, and complications due to inadvertent
insertion into normal tissues (blood vessels, rectum, bladder), rather than into residual tumor, may result.
Magnetic resonance-guided brachytherapy (MRBT) has significantly improved survival and reduced
complications caused by inadvertently radiating neighboring tissues. In order to locate the catheters properly
and to calculate radiation dose, a CT is required after the MRBT. This lengthens an already complex and labor-
intensive procedure, which also suffers from imperfect methods to identify residual tumor after EBRT and
before MRBT. Identifying normal tissues as residual tumor before MRBT may result in inadvertent treatment
with radiation of healthy tissues, which increases complications. MRI multi-parametric identification of post-
EBRT residual tumor, combined with actively-tracked catheter placement into the disease as seen on MR
scanning, can result in a more precise treatment volume, and faster and more accurate MRBT catheter
placement, leading to better outcomes and reduced complications. This should increase the use of MRBT in
treating cervical cancer, as well as recurrent endometrial, vaginal, prostate, and other cancers.
The proposed procedure utilizes several novel tools: (a) MRI sequences that map the tissue
parameters perfusion, diffusion, fibrosis and oxygenation in the post-EBRT pelvis, which are analyzed by
expert clinicians, and used to develop a method for providing refined remnant tumor maps; (b) a novel active-
obturator MRI coil which is placed in the vagina, that reduces MRI scan times by >50%; (c) flexible actively-
tracked metallic catheters, integrated with the new Elekta Venezia applicator, improving localization precision
and accelerating placement; and, (d) instantaneous intraoperative dose mapping, where catheter locations at
any time during placement are used to predict and guide what the clinician's best next move should be, such
as changing current catheter locations or adding more catheters. Together, these methods will culminate in
dose-optimized catheter placements that will lower tumor recurrence and limit radiation side effects.
This project is a collaboration between Johns Hopkins University and Elekta Inc. JHU radiation
oncologists, radiologists, medical physicists and MRI physicists, along with a panel of experts in identifying
remnant tumor, will work jointly with Elekta engineers to develop an innovative platform with broad applications
in radiation oncology. The tools developed are validated in a 20-patient cohort of cervical cancer patients.

Public health relevance
Cervical cancers are a leading cause of death among women worldwide. Treatment by implantation of radioactivity into the tumor with MR-guidance (MR- brachytherapy) has significantly improved survival. We accelerate MR- bracytherapy with better tumor detection and real-time dose optimization during implantation.